Risk and Geospatial Sciences Core

Risk and Geospatial Sciences Core (RGSC) ABSTRACT
The Texas A&M University Superfund Research Center is investigating the impacts of
environmental emergency-related contamination events across the source-to-outcome continuum,
including exposure, human health hazard, and mitigation of contamination and toxicity. In order to
achieve the Texas A&M Superfund Research Center’s ultimate goal of improving disaster response
after an environmental emergency, the Center’s Projects and Cores will need to make their findings
interpretable to first responders, impacted communities, and government bodies involved in site
management and cleanup. Therefore, the entire Center will be supported by a Risk and Geospatial
Sciences Core (RGSC), which has expertise in synthesizing, mapping, and visualizing relevant
scientific data and conclusions for use by those involved in decisions related to risk management.
The overall objective of the Risk and Geospatial Sciences Core is to provide the Center with data
and services for characterizing human health risks and the geographic distribution from
environmental mixtures created during disasters, thereby supporting the cohesion, relevance, and
implementation of project findings in the context of environmental risk assessment and risk
management. Our work will facilitate interaction among Center projects, while also serving as a
bridge to the Disaster Research Response, Community Engagement, and Administration and
Research Translation Cores. Key services provided will include human health risk assessment (Aim
1), geospatial data and analysis (Aim 2), and application to disaster research planning, sampling,
and interpretation (Aim 3). In Aim 1, human health risk modeling will be used to make inferences
about hazard or risk in the human population based on experimental or observational data, serving
as an essential bridge between scientific data and environmental policy decisions. In the context of
Superfund, human health risk modeling is used to demonstrate that exposure standards or
environmental remediation decisions both protect human health and reduce toxicity or risk. In Aim
2, geospatial data and analysis will be utilized to address the complex spatiotemporal dynamics of
environmental emergency-related contamination, providing essential geographical
contextualization and visualization to inform risk assessment and risk management. In Aim 3, the
Core will provide both risk and geospatial expertise to support rapid mobilization and sampling, as
well as timely and decision-relevant interpretation, coordinated by the Disaster Research Response
Core. As a whole, these services will support the Center’s overall goal by helping to interpret and
translate research project findings into information that can be used by varied stakeholders, from
communities to federal and state decision-makers, to assess the human health impact of
contaminant exposures after an environmental emergency, and enhance the planning, emergency
response, as well as long-term recovery and remediation efforts related to environmental disasters.

Public health relevance
Risk and Geospatial Sciences Core (RGSC) NARRATIVE The Risk and Geospatial Sciences Core will support the Center in synthesizing, mapping, and visualizing relevant scientific data and conclusions for use by local, State and Federal agencies involved risk management. These services will support the Center’s overall goal by helping to interpret and translate research project findings into solutions that can be used by different stakeholders, from communities to federal and state agencies, to assess the human health impact of contaminant exposures after an environmental emergency, and enhance the planning, emergency response, as well as long-term recovery and remediation efforts related to environmental disasters.